The Role of Proton-Mediated Signaling at the Neuromuscular Junction in ALS Models

PROJECT SUMMARY
Amyotrophic lateral sclerosis (ALS), also known as Lou Gehrig's disease, is marked by progressive loss of
motor neurons in the central and peripheral nervous system, leading to a devastating loss of motor function
and eventually death. There is no cure. Degeneration of the motor nerve terminal proceeds depending on the
muscle of interest, some being resistant and some being susceptible to denervation. Previous work suggests
that dysregulation of neuromuscular communication may be an early and important component of ALS. The
mechanism behind this phenomenon is not understood and is the focus of this proposal. Extracellular proton
(H+) concentration, measured as pH, is characteristic of ALS and has been shown to increase at several
tissues in ALS models, suggesting pH dysregulation in ALS pathology. Extracellular protons, being potent
neuromodulators, can influence the movement of ions on both the pre- and postsynaptic sides of the synapse
at the neuromuscular junction (NMJ). In ALS models, experimentally reducing acidosis and inhibiting matrix
metalloproteases was found to improve survival in ALS mouse models, whereas reducing pH buffering
capacity was detrimental to survival. We have described synaptic cleft pH transients associated with activity at
the healthy mouse NMJ. Our data suggest the activity-dependent pH transients at muscle and neuron are
segregated in the cleft due to the basal lamina, a specialized extracellular matrix, dividing the NMJ. These cleft
pH transients remain unknown in muscles susceptible to ALS. To address this gap in knowledge, we will
investigate synaptic cleft pH in two transgenic mouse lines that have been used to model familial and sporadic
ALS, SOD1-G93A and TDP-43-Q331K, respectively. Our central hypothesis is that dysregulation of
proton concentrations at NMJs in susceptible muscles contributes to the progression of ALS in model
mice. This hypothesis will be tested by measuring basal- and activity-dependent pH transients in the NMJ cleft
of ALS mutant and healthy mice using the genetically-encoded pH-sensitive fluorescent probe pHusion-Ex. We
will measure these changes in resistant and susceptible muscle groups: the soleus (a resistant muscle) and
the extensor digitorum longus (EDL, susceptible to ALS). Since we suggest presynaptic and postsynaptic pH
transients are segregated, both presynaptic and postsynaptic transients at the NMJ will be measured
separately. Electrophysiology recordings in muscle will be used to correlate neurotransmission with pH
changes and disease progression. Immunohistochemistry will be used to identify changes in basal lamina
composition and structure. To assess the effects of prolonged pH changes, pH will be stabilized at the mouse
soleus or EDL, induced via acidic and alkaline saline delivered by a surgically embedded osmotic pump. The
effect of induced acidification or alkalization will be monitored through immunohistochemistry, measuring NMJ
atrophy and denervation. These experiments will provide insight into the role of NMJ pH changes in ALS to
help us understand why some motor neurons and muscle groups remain resistant to disease progression.

Public health relevance
Project Narrative Amyotrophic lateral sclerosis (ALS) is a deadly neurodegenerative disease where the underlying mechanism remains unknown, and there are currently no identified treatments or cures that slow disease progression. An extracellular acidosis occurs at the muscle as the disease progresses and may contribute to synaptic degradation characteristic of early ALS symptomology. This research project aims to identify the role of pH changes and their origin at the neuromuscular junction in established ALS models.